Plk1 as a prognostic biomarker for prostate cancer

Title: Plk1 as a prognostic biomarker for prostate cancer
Abstract
Because androgen receptor (AR) signaling is essential for development of prostate cancer (PCa),
including castration-resistant prostate cancer (CRPC), androgen signaling inhibitors (ASI) are
becoming the first line treatment for CRPC. However, the limited clinical success of ASIs makes it
urgent to develop new approaches to treat ASI-resistant CRPC. Ionizing radiation is another major
approach to treat CRPC with limited efficacy. Olaparib, a PARP1 inhibitor, is recently developed and
used to target cancers with a defect in DNA repair, such as BRCA mutations. Unfortunately, the usage
of olaparib in CRPC is profoundly limited by the fact that BRCA mutations only occur in low
percentages of PCa. Thus, identifying additional critical regulators that control DNA damage response
(DDR) is of significance as it will identify specific patient populations who will be responsive to olaparib.
The objective is to define the role of polo-like kinase 1 (Plk1) in regulating DDR and to exploit its unique
impact on the efficacy of olaparib for ASI-resistant CRPC patients. The central hypothesis is that Plk1
phosphorylation of Mre11, a component of MRN (Mre11/Rad50/Nbs1) complex, and MDC1 (mediator
of DNA damage checkpoint 1), leads to premature termination of DNA damage checkpoint, reduced
DNA repair, thus increased olabparib efficacy based on the concept of synthetic lethality. Our data
show that Plk1 directly phosphorylates Mre11, whose activation is the first step in response to DNA
damage and that Plk1 phosphorylation of Mre11 leads to recovery from DNA damage checkpoint and
reduced DNA repair. We also show that MDC1, a protein that further amplifies DDR signals, is a Plk1
substrate. Our hypothesis will be tested by pursuing three Specific Aims - (1) to dissect how Plk1
phosphorylation of Mre11 regulates the MRN complex; (2) to test whether Plk1 phosphorylation of
MDC1 contributes to premature termination of checkpoint; and (3) to determine whether Plk1 is a
prognostic biomarker for PCa. These complementary aims will be accomplished using biochemical
analyses of signaling intermediates and employing both cell culture systems and genetic strategies
with inducible mouse models. The rationale for the research is that it will probe the importance of Plk1
to DDR and to examine whether Plk1 can be a predictable biomarker for the efficacy of olaparib in
CRPC. This contribution is significant because, if positive, the results of the proposed study will support
an immediate clinical trial to compare the efficacy of olaparib in CRPC patients carrying different levels
of Plk1. The research is innovative as it approaches the disease from a novel Plk1 signaling pathway,
challenging the traditional view that Plk1 functions solely to regulate mitotic events. These studies
provide a new paradigm for therapies by identifying the key regulator of DDR that is critical for the
efficacy of olaparib in CRPC.

Public health relevance
Narrative The proposed research is relevant to public health because it focuses on discovery of novel signaling pathways that drive castration-resistant prostate cancer. These studies will establish new avenues of investigation to develop improved therapeutics to treat this deadly disease and to greatly improve patient outcome. Thus, the proposed research is relevant to NCI's mission of fostering creative discoveries and innovative research strategies for protecting and improving health and reducing the burdens associated with cancer.